Core Laboratory for Advanced Cancer Image Analysis

1 ABSTRACT: The goal of this proposal is to provide technically-advanced support for the specific aims of
2 selected NCI-funded projects for medical imaging affiliated with the University of Washington (UW), The
3 University of Pennsylvania, the NCI Quantitative Imaging Network (QIN), and the NCTN ECOG-ACRIN
4 cooperative group. My medical imaging career began at UW in 1985, where I was fortunate to work with Drs.
5 Michael Graham and Alex Spence, who laid the foundation for quantitative analysis in oncology. My early work
6 in PET imaging revolved around managing animal imaging projects, a full biochemistry lab and a nascent
7 human PET imaging program. As PET imaging developed under NCI grant P01-CA042045 (PI; Krohn, KA),
8 we transitioned to human imaging and clinical trials research, probing various biochemical pathways using
9 many PET tracers. I developed avidity for kinetic modeling of dynamic PET image data, initially with Drs.
10 James Bassingwaithe and Michael Graham, and later in collaboration with Drs. Tony Shields, David Mankoff,
11 Janet Eary, Hannah Linden and Paul Kinahan, all of them funded by NCI grants. As an NCI R50 recipient
12 (R50-CA270211), I am currently Director of a Core Laboratory for Advanced image analysis and a member of
13 Dr. Kinahan’s U24 (U24-CA264044) CIRP team. I have responsibility for participating in working groups of the
14 QIN, CIRP, planning PET imaging projects, imaging protocols and designing novel data analysis methods. I
15 am a senior contributor to our UW program as well as a provider of innovative approaches to quantitative
16 image analysis and data simulations for numerous cancer imaging projects. Due to the cost of imaging,
17 radiation dose and other issues, my personal ambition is to extract as much quantitative information as
18 possible from well-designed and executed cancer imaging studies. My career goal is to provide independent,
19 but collaborative, support for the specific aims of NCI grants for medical imaging projects at UW, UPenn, the
20 QIN, CIRP and ECOG-ACRIN. Additionally, I have national recognition as manager of the ECOG-ACRIN-UW
21 PET Core Lab, a member of the ECOG-ACRIN Head & Neck, Experimental Imaging, Radiomics, Quantitative
22 Imaging and Brain Tumor Committees, and a key member of the NCI/CIP QIN Working Groups. The innovative
23 protocols I developed for dynamic imaging are a substantial improvement for extracting quantitative information
24 from dynamic PET, and are now a national clinical trials standard. I routinely present my advanced PET
25 imaging results at national and international scientific meetings (EORTC, SNMMI, WMIC, EMIM, IEEE, ECOG-
26 ACRIN and QIN/NCI) and publish/review manuscripts annually. Over the last R50 period I had 26 publications,
27 6 data reports and 40 presentations. In summary, I have developed a nationally recognized advanced lab for
28 image analysis, funded entirely through NCI grants for 35 years. The overall benefit NCI receives for sharing
29 my labor across NCI projects will have an impact on current and new investigators, providing them with
30 quantitative methods for PET/CT and MRI cancer image data using robust, repeatable and validated methods.

Public health relevance
Project Narrative (3 Sentences) As Director of the Core Laboratory for Advanced Cancer Image Analysis at the University of Washington, my approach for both multi-center and cooperative group research analysis begins with consultation during regular meetings encouraging the programs to collect as much information as practical for the study, periodically provide acquisition, reconstruction and imaging protocols, laboratory analysis for tracer metabolites, manage patient imaging studies, analyze the collected imaging and patient meta-data, provide advanced image processing procedures, generate model simulations, present the analysis results at conferences and through peer-reviewed publications. To ensure fulfillment of the specific aims I would actively pursue detailed analysis of the data including development of data structures for managing the information, providing both common and innovative data analysis methodology, performing simulations if necessary and co-author publications with particular emphasis on writing the technical methods of analysis of advanced imaging studies for a variety of cancers that benefits the scientific community.